IGF::OT::IGF TASK ORDER 38: MODELING CONSEQUENCES OF COLLABORATIVE DELIBERATION MEETING

The Health Delivery Research Program (HDRP) has meeting support needs related to the Modeling Consequences of Collaborative Deliberation Meeting which will take place at NCI Shady Grove (9609 Medical Center Drive; Rockville, MD) from June 16-17, 2016.